Postbaccalaureate Research Education Program (PREP)

PROJECT SUMMARY
The long term goal of Mount Sinai's Post-baccalaureate Research Education Program (Mount Sinai PREP) is
to make a significant contribution to increasing the number of biomedical scientists from underrepresented
minority groups, socioeconomically disadvantaged backgrounds or those who are challenged by a disability.
We aim to prepare recent college graduates from these groups to enroll and succeed in competitive PhD and
MD/PhD programs, and then complete postdoctoral or residency/fellowship training before entering careers in
which they can contribute to biomedical research, drug development, or research on health and health care
disparities. Now in its 17th year, Mount Sinai PREP alumni have garnered 24 PhD degrees, while completion of
4 more PhD degrees is also expected by the summer. During their predoctoral work, 24 Mount Sinai PREP
alumni were supported by traineeships on T32 training grants, 10 were awarded F31 fellowships and many
other prestigious fellowships were obtained, e.g. 3 UNCF/Merck awards. All the PREP alumni who completed
PhD programs to date have entered postdoctoral work: 19 in academic settings, with prestigious fellowships
including the CDC Infectious Disease Fellowship and HHMI Life Sciences Award; 1 at NIAID, with an IRTA
award; 1 at the FDA with an FDA Commissioner's award; and 1 who pursued postdoctoral work at
GlaxoSmithKline. Enhanced recruitment efforts, program evaluation (self-evaluation and external evaluation)
and ongoing program development have enabled the program to achieve and benefit from a large applicant
pool and maintain an accept/enter ratio between 1 and 1.2. Central strategies of Mount Sinai PREP include the
following. We strive to ensure that each PREP scholar has a laboratory placement with an excellent faculty
research mentor, supportive peer mentors, and an opportunity to work on a cutting-edge project of interest that
develops analytical, conceptual and technical skills. We expect PREP scholars to integrate into laboratory
activities such as lab meetings, journal clubs, and parties. They are also expected to integrate into the PREP
community and activities such as workshops that build research, presentation, writing skills, or initiate a
discussion of psychosocial well-being. PREP activities also include peer-led WIPs/Journal Clubs, lunches with
advisors and guests with interesting paths to share, and encounters with PREP alumni. We further promote
their integration into activities of the PhD, MD/PhD and master's student community of the Graduate School,
which whom PREP scholars interact in courses, seminars, and both outreach and social activities. The
Program joins a Regional PREP Symposium, at which the PREP scholars present their work and network. The
Program will also follow up on a well-received 10 year Reunion/Retreat with a similar event every 5 years. The
Program maintains close touch with PREP alumni through emails, reunions, and alumni visits.

Public health relevance
PROJECT NARRATIVE Mount Sinai PREP seeks to increase the participation of individuals from underrepresented minority groups and socioeconomically disadvantaged individuals at the cutting-edge levels of biomedical research, and seeks to accommodate individuals with disabilities. Research shows that diverse groups function more effectively and innovatively than groups lacking diversity. Major benefits to public health will result from further diversification of the biomedical work-force and a diverse work-force will increase engagement and expert focus on problems related to health and health care disparities, which are in need of such focus.